Microbial Genomic Determinants of Antibiotic Treatment Failure in Staphylococcus aureus Bacteremia

ABSTRACT
Staphylococcus aureus bacteremia (SAB) is a common and frequently lethal infection. Despite appropriate
antibiotic therapy, many patients will experience treatment failure in the form of relapsed SAB (>1 episode with
the same isolate) and persistent SAB (>5 days of persistently positive blood cultures). Antibiotic treatment failure
is driven by the interplay of host, treatment and microbial factors. Despite decades of research focusing on
treatment and patient factors, mortality from SAB remains at 25% and we still know very little about the role of
microbial biology in treatment failure. Innovative approaches are required to address this important knowledge
gap. To address this problem, Dr. Parsons’ long-term goal is to use patient clinical data, bacterial clinical isolates
and focused genomic and laboratory studies to determine the link between bacterial biology on the bench and
clinical outcomes in patients. The short-term goal of this proposal is to identify genomic polymorphisms
influencing antibiotic treatment failure in SAB patients. The central hypothesis posits that specific genomic
changes lead to an enhanced ability to evade the innate immune system and antibiotics, which drives worse
clinical outcomes in patients. This will be tested through two specific aims. Aim 1 will identify bacterial genotypes
associated with SAB antibiotic treatment failure using murine in-vivo evolution model. Dr. Parsons has developed
several S. aureus strains with enhanced virulence and increased antibiotic tolerance via serial passaging through
a murine bloodstream. Dr. Parsons will identify genomic changes within these isolates and examine the clinical
relevance by screening for these mutations in a prospectively enrolled cohort of patients with relapsed SAB. Aim
2 will identify new bacterial genotypes associated with SAB antibiotic treatment failure. This aim will use a unique
high-throughput sequencing and a bacterial Genome Wide Association Study (GWAS) pipeline combined with
the world’s largest SAB biorepository to identify genomic variants associated with persistent SAB and relapsed
SAB. The work will also focus on unraveling the biological mechanism driving persistent bacteremia of two
polymorphisms previously identified using this GWAS technology; plsX and metN2. Identification of genes
associated with antibiotic treatment failure in humans will increase our understanding of the devastating
outcomes associated with SAB and identify new drug candidates aimed at reducing S. aureus virulence and
sensitizing the bacteria to antibiotics. Dr. Parsons’ training to date has focused on the biochemistry of S. aureus
metabolism. He will supplement this experience with training in genomics and observational clinical studies to
focus on the link between bacterial genomic variations and clinical outcomes. The skills and mentoring acquired
during this award will facilitate Dr. Parsons’ development into an independent physician-scientist focused on
bacterial determinants of clinical outcomes in bacterial bloodstream infections.

Public health relevance
PROJECT NARRATIVE Staphylococcus aureus bacteremia is the most common cause of death due to bloodstream infection in the world, with mortality estimated at 25%. We simply do not understand why some patients experience poor outcomes, despite appropriate antibiotic therapy. This proposal will determine how genomic alterations in S. aureus contributes to antibiotic failure in S. aureus bacteremia patients.